Project 3: PHLDA2-mediated Phospholipid Oxidation in Ferroptosis and Tumor Suppression

Project Summary
Cells employ several ferroptosis surveillance pathways to protect themselves from inappropriate ferroptosis
including GPX4-mediated reduction of phospholipid peroxides, the antioxidant activity by free radical trappers such as
CoQ10 and MUFA-mediated phospholipid remodeling. Interestingly, although the canonical ferroptosis response is
suppressed by both GPX4-dependent and GPX4-independent manners, initiation of ferroptosis in cells often requires
the treatment of GPX4 inhibitors. Moreover, only oxidized forms of phosphatidylethanolamines phospholipids (PL-
PUFA (PE)-OOH) are associated with execution of ferroptosis induced by GPX4 inhibitors. Thus, it remains unclear
whether oxidation of other classes of phospholipids is directly involved in triggering ferroptosis and how non-canonical
ferroptosis responses are regulated in vivo. In our preliminary studies, we have discovered a new non-canonical
ferroptosis pathway controlled by pleckstrin homology-like domain family A member 2 (PHLDA2), a membrane-
associated phospholipid binding protein through the Crispr-Cas9 screening. In contrast to the canonical ferroptosis
induced by GPX4 inhibitors, PHLDA2-mediated ferroptosis is neither ACSL4-dependent nor acts through peroxidation
of phosphatidylethanolamine (PE); instead, PHLDA2 has a strong affinity for phosphatidic acid (PA) and, by recruiting
ALOX12 lipoxygenase, PHLDA2 catalyzes peroxidation of PA (PL-PUFA (PA)-OOH) to induce ferroptosis upon high
levels of ROS. To fuel their enhanced growth and proliferation, cancer cells undergo metabolic reprogramming,
generally accompanied by increased ROS production. Indeed, ROS-induced ferroptosis occurs in vivo in tumor cells
without any treatment of GPX4 inhibitors and strikingly, loss of PHLDA2 abrogates ROS-induced ferroptosis and
promotes tumor growth in mouse xenograft tumor models. More importantly, by using PHLDA2-null mice, we found
that PHLDA2-mediated ferroptosis is crucial for tumor development in well-established tumor mouse models. These
data demonstrate that PHLDA2-mediated phospholipid peroxidation triggers a non-canonical ferroptosis response
critical for tumor suppression in both immunodeficient and immunocompetent environments. The central hypothesis to
be tested here is whether PHLDA2-mediated ferroptosis plays a key role in tumor growth suppression without the
treatment of GPX4 inhibitors and how this new pathway is modulated by the ferroptosis surveillance pathways involving
MBOAT1/2 and ADCK3 in vivo. In Aim 1, we will elucidate the molecular mechanism of PHLDA2-mediated ferroptosis
through lipid peroxidation and its regulation by ferroptosis surveillance pathways involving MBOAT1/2 and ADCK3. In
Aim 2, we will dissect the physiological significance of PHLDA2-dependent ferroptosis in regulating tumor growth of
breast and liver tumors by using different mouse models.

Public health relevance
Project Narrative Ferroptosis has been shown to be a natural defense against cancer development. The central hypothesis to be tested here is whether PHLDA2-mediated non-canonical ferroptosis plays a key role in tumor growth suppression of breast and liver cancers and how this new non-canonical ferroptosis response is modulated by the ferroptosis surveillance pathways involving MBOAT1/2 and ADCK3 in vivo.